Georgia Clinical & Translational Science Alliance (Georgia CTSA)

The Georgia Clinical and Translational Science Alliance (Georgia CTSA) serves as the “hub” for the
complimentary academic, healthcare, and translational partners that support high quality translational science
and clinical research, innovative research methods, training, and career development to improve health equity
in urban and rural communities across Georgia, the southeast region, and nation.
Academic partners include Emory University, Morehouse School of Medicine, the University of Georgia,
and the Georgia Institute of Technology. Healthcare partners include Emory Healthcare, Morehouse
Healthcare, Children’s Healthcare of Atlanta, Morehouse Healthcare, the Atlanta VA Medical Center, Grady
Health System, and Morehouse Community Physicians Network. Translational science partners include Yerkes
National Primate Research Center (Emory), the Georgia Research Alliance, Georgia Bio and the US Centers
for Disease Control and Prevention. The academic, healthcare, and translational partners form the “spokes” of
the Georgia CTSA.
Since 2007, the Georgia CTSA hub has served as an integrated research and training environment for
translational and clinical science, to develop, demonstrate, and disseminate methods and technologies that
improve efficiency and quality across the translational research spectrum. The overall purpose of the Georgia
CTSA is to deliver scientific and systems change that solve the many outstanding problems limiting the
efficiency, effectiveness, and reach of clinical translational research, and thus get more treatments to more
patients more quickly across the country.
The Georgia CTSA hub functions as the statewide center of innovation in translational science and
operations and joins the national collaboration of hubs to facilitate innovation in multi-center research,
harmonization of standards and best practices, enhance translational training through sharing curricula and
online training modules/courses, and provide opportunities for cross-hub and sector research training and
career development opportunities, both within and outside of the CTSA Program. Realizing these synergies will
justify and maximize the nation’s investment into the CTSA Program.

Public health relevance
Created in response to the NIH CTSA program, the Georgia Clinical & Translational Science Alliance (Georgia CTSA) supports high quality collaborative translational science locally, regionally, and nationally; fosters scientific and operational innovation to improve the efficiency and effectiveness of clinical and translational research; and creates, provides, and disseminates domain-specific translational science training and workforce development.